In Utero HIV Exposure and Metabolic Disease Risk in HIV-Uninfected Young Adults

Project(Summary(
With the global implementation of prenatal antiretroviral therapy (ART), over 18 million individuals born to
mothers with HIV have been HIV-exposed but uninfected (HEU). While HEU infants and children are known to
be at increased risk of adverse health outcomes, the long-term implications of in utero HIV/ART exposure into
adulthood have not been well explored. The candidate has generated novel preliminary data to show an
increased prevalence of obesity in HEU adolescents and young adults versus well-matched controls. These
findings convey the compelling need to characterize the extent of metabolic and immune dysregulation among
HEU young adults, and to delineate molecular pathways that may underlie this phenotype. Candidate: Dr.
Fourman is an endocrinologist and clinical investigator at Harvard Medical School dedicated to identifying
novel mechanisms and treatment strategies for metabolic disease. Her work thus far has centered on
metabolic complications of HIV. Her overarching career goal is to become an independent R01-funded clinical
investigator committed to preventing and treating obesity and metabolic disease in the rapidly growing HEU
population, as well as in other groups exposed to abnormal intrauterine environments. Training: To achieve
this goal, Dr. Fourman has developed a career development plan that will provide targeted training in
developmental origins of health and disease (DOHaD), immunologic aspects of metabolic disease, design and
interpretation of epigenetic studies, and social and behavioral determinants of health. Mentors: The
candidate's career development and research plans will be overseen by her primary mentor, Dr. Steven
Grinspoon, who is an internationally recognized leader in metabolic disease research in HIV. The applicant
also will be supported by a highly invested team of co-mentors and advisors with expertise in DOHaD,
epigenetics, immunology, infectious diseases, epidemiology, and biostatistics. Research: Dr. Fourman will
leverage her background in endocrinology and HIV to test the innovative hypothesis that the HIV intrauterine
environment influences fetal development to confer an increased susceptibility to metabolic and immune
dysregulation later in life. Specifically, she will conduct the first prospective study that compares long-term
health outcomes in HEU young adults versus well-matched controls. In Aims 1-2, Dr. Fourman will delineate
the downstream metabolic and immune sequelae of in utero HIV/ART exposure among HEU young adults. In
Aim 3, she will investigate the contribution of epigenetic modifications to the HEU phenotype. This project
stands to establish in utero HIV/ART exposure as a previously unrecognized risk factor for metabolic disease.
Only by defining long-term metabolic and immune perturbations among the HEU population can screening and
prevention strategies be optimized for this group. Furthermore, this Award will launch Dr. Fourman on an
independent career trajectory, distinct from that of her mentors, to not only advance the health of the HEU
population, but also to investigate the developmental origins of metabolic disease in diverse clinical contexts.

Public health relevance
Project(Narrative( HIV-uninfected individuals born to mothers with HIV are known to exhibit adverse health outcomes in early life, yet the long-term clinical consequences for this population – exceeding 18 million people worldwide – are largely unknown. This project will delineate metabolic and immune sequelae of in utero HIV exposure among HIV-uninfected young adults, and identify mechanisms that may contribute to these outcomes. Only by characterizing lifelong disease risk among HIV-exposed but uninfected individuals can we optimize screening, prevention, and treatment strategies for this group.